Imaging and Electrophysiology

Imaging and Electrophysiology - Project Summary
The goal of the Imaging and Electrophysiology Core Module (IECM) is to provide shared resources to the
investigators of the vision research center (VRC) for imaging and electrophysiological recording. The core
instruments of the IECM support imaging (confocal and two-photon) and electrophysiology (patch clamp in
vitro, simultaneous with 2P imaging) as well as multiunit retinal recording using a multi-electrode array. The
IECM also subsidizes the use of two confocal microscopes and a cSLO-OCT system for imaging of retina in
vivo in canine. The IECM offers full technical assistance through trained personnel to facilitate use of the
instruments. Importantly, the IECM also provides a hub of for collaborative work among members of the VRC
by enabling multidisciplinary projects about the normal structure and function of the visual system and its
pathological alterations.